Optimizing detection and prediction of changes in cognitive function in multiple sclerosis with novel ambulatory assessment methods

Multiple sclerosis (MS) is a chronic disease of the central nervous system that affects approximately 1 million
people in the US and is the #1 cause of non-traumatic disability in young adults. Cognitive dysfunction,
including deficits in processing speed, visual memory, verbal fluency, working memory, and executive
functioning, is one of the most common problems in MS. Cognitive dysfunction in MS exerts a dire impact on
many aspects of health-related quality of life. Unfortunately, progress in developing preventative,
compensatory and restorative interventions for cognitive dysfunction in MS is stymied by major gaps in our
knowledge of its natural history, mechanisms, and impacts where it matters most – in the everyday lives of
people with MS. Our understanding of cognitive function in MS is restricted by two major factors:
measurement limitations and lack of scientific attention to potential contributors to and consequences of
declines in cognition. This study leverages advances in technology-assisted ambulatory assessment
techniques to provide a unique and multidimensional window onto the experience of cognitive dysfunction in
the everyday lives of people with MS. In this study, we will use multiple complementary ambulatory
assessment strategies to better understand cognitive dysfunction in MS. A customized smartphone app will
be used to administer a battery of ambulatory cognitive tests that are designed specifically for serial
administration in the lived environment as well as ecological momentary assessments (real-time assessment)
of self-reported symptoms and functioning as a person goes about daily life. The smartphone app will be
paired with accelerometer technology, which will provide objective, continuous, and unobtrusive measures of
physical activity. Ambulatory assessments will be administered in a “measurement burst design,”
incorporating bursts of intensive repeated assessment over two weeks, with bursts repeated longitudinally, at
baseline, and 1- and 2- year follow-up. Using these innovative assessment measures and methods, we will
test whether ambulatory measures of subjective and objective cognitive function are more sensitive to
longitudinal changes (over 2 years) in cognitive functioning than conventional “snapshot” clinic-based
assessments. We will also examine short- (days) and long-term (years) temporal associations between
potentially modifiable factors - physical activity, sleep, fatigue, pain, mood, and stress – and changes in
cognitive functioning. Finally, we will examine the association between cognitive functioning and other key
outcomes - social and physical functioning. This work is designed to better characterize the natural history of
cognitive dysfunction in MS, to identify factors that contribute to cognitive functioning in daily life, and to
highlight functional domains that might be impacted by changes in cognitive function. Ultimately, this work will
indicate optimal methods for assessing cognitive functioning and will guide development and testing of
preventative, compensatory, and/or restorative treatments for cognitive dysfunction in MS.

Public health relevance
People with multiple sclerosis (MS) commonly experience problems with cognitive function, but current assessment methods only provide a “snapshot” of cognition and fail to capture its true nature where it matters most, in daily life. The proposed research will examine the utility of novel mobile app-based cognitive tests to characterize changes in cognitive function, while simultaneously collecting data on important modifiable factors (e.g., physical activity, sleep, fatigue) that may impact cognitive function. Better understanding of daily variability in cognitive function, predictors of cognitive decline and the impact of cognitive dysfunction is crucial to developing treatments that can improve the functioning and health-related quality of life of people with MS.